Chemoenzymatic Synthesis of Libraries of Sulfoglycopeptides

Abstract
The Zhu lab uses synthetic chemistry to answer questions related to post-translational modifications (PTMs) of
proteins, specifically, O-glycosylation and Tyrosine sulfation. Co-localization of Tyrosine sulfation and O-
glycosylation on Serine/Threonine (CSOG) is an emerging global PTM pattern. CSOG exists in a variety of
proteins, like G-protein coupled receptors, proteins of the hemostatic system, pathogen encoded proteins, and
adhesion molecules. CSOG plays critical roles in modulating the binding/signaling networks through those
proteins and their binding ligands/proteins. However, detailed information about how the cells or biological
systems use fine-tuning CSOG structures to modulate corresponding binding/signaling pathways is lacking. One
of the main gaps for studying the relationship is the lack of structure-defined molecules bearing CSOG. To fill up
the gap, a generalized strategy is needed to synthesize those molecules so we can get access to the massive,
diversified structures of CSOG. Then we can map out the relationship between the fine-tuning structures of
CSOG and their corresponding binding/signaling pathways. We can also use these structure-defined molecules
to develop reliable methods for characterizing CSOG from different proteins. Furthermore, we can combine
synthetic chemistry and computational chemistry to develop robust computational chemistry methods for
predicting meaningful bindings and designing probes/molecules to target certain specific bindings.
Our lab currently focuses on applying site-selective sulfation in chemoenzymatic synthesis of glycopeptides to
provide a generalized strategy for the access to the complex molecules with CSOG. Towards this goal, our lab
developed a Ag2O promoted method for large-scale synthesis of the two critical intermediates, GalN3-α-Fmoc-
Ser/Thr, for future synthesis of all the needed 16 glyco-amino acids. We have achieved the synthesis of core 2
containing glyco-amino acid in gram scale. For site-selective sulfation, we developed 2-Cl-trityl protecting group
as a new way for doing site-selective sulfation. For enzymatic extension of O-glycans on sulfoglycopeptides, our
initial attempt demonstrated that the enzyme worked on the sulfoglycopeptide even with protecting groups on
the sulfate groups. We expect to generalize this strategy to synthesize libraries of sulfoglycopeptides in this
proposal.
This MIRA funding will support us to use our generalized synthetic strategy to initiate the following major projects:
(1) Build compound libraries to map out the complex network between COSG patterns and corresponding
binding/signaling pathways; (2) Use structure-defined molecules with CSOG to develop reliable methods to
characterize CSOG structures from different proteins; (3) Use our binding data and computational methods to
develop robust computational chemistry methods to predict meaningful binding and design probes/molecules to
target specific bindings.

Public health relevance
Co-localization of Tyrosine sulfation and O-glycosylation plays critical roles in binding/signaling pathways in biological systems. This proposal aims to use an innovative synthetic chemistry tool to provide a comprehensive understanding of this special arrangement of the two post- translational modifications. We will use structure-defined molecules to map out the complex network of the bindings/signaling pathways, develop new ways of characterizing the structures, and predict potential bindings and binding structures.